The effect of adventitial vein cells on vein graft neointimal hyperplasia

Veterans are disproportionately affected by peripheral artery disease (PAD) and coronary artery disease
(CAD) because of high rates of tobacco use in the veteran population. Up to one-third of the saphenous
vein bypass grafts performed for either PAD or CAD fail secondary to a process called neointimal
hyperplasia. We have established a new model to study saphenous vein grafts by implanting human
saphenous veins into immunodeficient nude rats. This model develops significant neointimal
hyperplasia, unlike prior animal models using animal vein grafts. Our previous work on human
saphenous vein grafts suggest that adventitial cells may prevent neointimal hyperplasia and graft failure.
We have also been testing a novel therapeutic agent SB-030, which when administered luminally,
decreases the neointimal hyperplasia reaction to angioplasty-induced arterial injury in humans
presumably by inhibiting smooth muscle cell proliferation. This proposal will test whether adventitial
cells can be used therapeutically to decrease neointimal hyperplasia. In addition, we will test whether
inhibiting adventitial cell proliferation by applying SB-030 to the adventitia causes increased neointimal
hyperplasia. In contrast, we expect luminal application of SB-030 will decrease neointimal hyperplasia by
inhibiting smooth muscle cells. These results will be relevant for future treatment of vein grafts with SB-
030 or other therapeutics that target both adventitial cells and medial smooth muscle cells. Successful
completion of this proposal will better establish the new model, demonstrate whether adventitial cells
reduce neointimal hyperplasia, and determine whether adventitial or luminal application of a novel
therapeutic will best inhibit neointimal hyperplasia. This will lead to new therapies to improve the
success of vein bypass grafts for patients.

Public health relevance
Peripheral artery bypass and coronary artery bypass grafting using saphenous veins are limb and life- saving operations for Veterans, who are disproportionately affected because of high rates of tobacco use, diabetes, and obesity. Unfortunately, up to one-third of these bypass grafts fail within one to two years after placement, and there are no known therapies that decrease this failure rate, making it a highly significant clinical problem. This proposal seeks to take a new therapeutic approach to treating saphenous vein bypass grafts to prevent mid-term failure, with the goal of translating these findings to the many Veterans undergoing these procedures yearly.